Genetic Epidemiology

Many of the investigations in this genetic epidemiology project arise from observations in families at high risk of cancer or in other etiologic studies. Recent analyses of a case-control study of 718 non-Hispanic white patients with cutaneous melanoma from melanoma clinics in Philadelphia and San Francisco showed modest, non-significant decreased risk of melanoma among susceptible individuals who used sunscreens most of the time. Young women were the individuals most likely to use tanning beds, and use was related to melanoma risk. Those who used tanning beds were more likely to have melanomas in sites not usually exposed to sun. These observations may help explain the increasing rates and changing distribution of melanoma among young women in the general population. Questionnaire data, tumor, and DNA from a case-control study of 183 incident melanoma cases and 179 controls conducted in North-Eastern Italy, showed a strong association between germline variants in the melanocortin-1 receptor (MC1R) gene and melanoma with somatic mutations in the BRAF oncogene, in subjects with melanoma arising on sun exposed areas of the body and with limited chronic solar damage. We confirmed this association in an independent population. Data from other Mediterranean populations have been collected and harmonized to extend the analyses of association between melanoma risk and several risk factors, also including immune-related genes. In this combined sample, we identified suggestive evidence for a role of telomere-related genes in the etiology of melanoma. Moreover, a genome-wide association study of melanoma cases from Mediterranean countries and appropriate controls is planned. Melanoma tissue specimens have been collected and analyses of melanoma lesions in relation to sun exposure, body site, nevi count, susceptibility genes and molecular alterations is planned. We have selected a panel of 60 candidate genes for melanoma development and progression and we are currently testing the DNA extracted from 200 FFPE lesions using this gene panel. Based on the results, we may extend the analyses to a larger sample of melanoma lesions for a more accurate molecular classification of the disease. One of the potential pathways that leads to the development of melanoma includes the loss of regulation of common melanocytic nevi, which acquire atypic or dysplastic characteristics that can further evolve in neoplasia. To study this pathway, we are currently collecting multiple tissue samples of normal skin, common melanocytic nevi, dysplastic nevi, melanoma and metastasis from melanoma from the same subjects from Italy and Spain. We are planning to study the expression and presence of mutations in multiple genes of the cell cycle, and transduction pathways in the serial tissue samples and germline DNA to explore the mechanisms involved in melanoma development through nevi. Chordoma is a rare primary malignant bone tumor that arises mainly in the axial skeleton from rests of embryonic notochordal stem cells that failed to undergo normal regression. An expanded project has been developed to collect personal and family medical history, buccal cells and slides of tumor tissue from sporadic chordoma patients from throughout the United States and Canada. The project will collect up to 400 patients diagnosed with chordoma at any age and anatomic site. Using buccal cell DNA extracted from 100 sporadic chordoma patients we have recruited in this study, we identified several common and rare variants in the T gene that are related to disease risk. Our findings provide more evidence for the importance of genetic variations in the T gene in the pathogenesis of both familial and sporadic chordoma. Currently, we are using whole-exome sequencing to identify additional susceptibility genes in chordoma families without T duplication as well as sporadic chordoma cases. We are also collaborating with cancer hospitals in Beijing, China to collect germline DNA andchordoma tumor tissues from Chinese chordoma patients to follow up on variants we identify from the exome sequencing project. Alterations in the normal microbiome are increasingly recognized to play a role in human disease. Using protocols adapted from the NIH Human Microbiome Project, we are conducting pilot studies to evaluate differences in the oral microbiome between smokers and nonsmokers. Pilot studies are being conducted in collaboration with investigators from the School of Medicine and Dentistry, University of Rochester. Using data we collected from the Polish Breast Cancer Study and breast cancer association consortium (BCAC), we demonstrated that risk factors for breast cancer and morphology and molecular characteristics of terminal duct lobular units (TDLUs), the structures from which breast cancers arise, varied by molecular subtypes. In addition, we found that parity-related molecular changes were preserved in breast cancer patients with ER-positive tumors but disrupted in patients with ER-negative tumors, a finding that may partially account for the observed differential effect of parity in these two tumor subtypes. We are currently analyzing the expression profiling data to identify molecular signatures for TDLU involution and parity. Recently, we initiated several breast cancer projects with clinicians and epidemiologists in Asian countries to study breast cancer among Asian women. Using data collected from Sarawak, Malaysia, we showed that the overrepresentation of early-onset and ER-negative tumors among Malaysian women was largely due to the disproportionally lower incidence of late-onset ER-positive tumors rather than an absolute increase in ER-negative cancers. To extend the finding, we used cancer registry data obtained from several Asian countries (Singapore, Taiwan, Hong Kong, China, Korea) and reported that, after the adjustment of period and cohort effects, the age effects of breast cancer may be more similar between Asian and Western women than previously recognized. Recently, we have developed a new tissue-based breast cancer study in Hong Kong, in which we plan to collect breast tumor and adjacent normal tissues from up to 1,000 breast cancer cases with the goal of identifying molecular changes that are related to risk and clinical factors for breast cancer subtypes among Chinese women in Hong Kong. We are continuing to conduct studies of hematologic malignancies using the Swedish linked registry data to complement the family studies in GEB. We conducted a study using linked Swedish registry databases to determine whether survival after MPN diagnosis was related to whether the patient was familial or sporadic. We did not find a survival difference in familial patients compared to sporadic. Our novel findings on similar survival in familial and sporadic MPN patients are consistent with earlier reports on comparable clinical presentation and rate of thrombosis in familial and sporadic MPN patients. Using similar methodology to evaluate survival, we found that familial WM/LPL patients had significantly worse survival than did sporadic patients. These results support the theory that genetic susceptibility predisposes patients to a more severe form of LPL/WM.Patients with Hodgkin lymphoma (HL) have a well-characterized immune deficiency of T cell function, originally identified by increased susceptibility to certain infections. Using our Swedish registry data, we evaluated the subsequent risk of HL in relation to a broad range of infectious and inflammatory conditions, using unconditional logistic regression. A previous history of any reported infection was associated with a significantly increased risk of HL... Our results suggest that underlying immune deficiency is a primary phenomenon in HL. Alternatively, certain infectious agents may be potential HL triggers.